Improving integration of treatment burden information in primary care for older adults with multiple chronic conditions

PROJECT SUMMARY/ABSTRACT
Over two-thirds of older adults in the US are diagnosed with multiple chronic conditions (MCCs). Due to
the increased complexity of their care, these adults are at higher risk of experiencing treatment burden,
defined as the patient-perceived effort of accommodating health care into one’s life, including cognitive
load, time, and cost. Guidelines currently recommend reducing treatment burden as a part of the care of
older adults with MCCs, yet no evidence-based approach exists to support this goal. Existing validated
methods for assessing treatment burden, such as the Treatment Burden Questionnaire (TBQ), are lengthy
and require information not routinely collected in clinical care (i.e. inaccessible in electronic health records
or claims data), making them difficult to automate and implement in primary care settings where most
older adults receive care. There is a critical need for a scalable, systematic approach to evaluate and
respond to treatment burden, tailored to older adults with MCCs. The objective of this proposal is to
establish a foundation for the integration of treatment burden information in primary care for older adults
with MCCs. Mentored by an outstanding team of experts in aging research, I will: 1) Develop a scalable
model to estimate TBQ treatment burden scores in older adults with MCCs, using data from the nationally-
representative 2022 Health and Retirement Study TBQ linked with Medicare claims data, and 2) Conduct
qualitative interviews with primary care providers (n=10), their patients aged ≥65 with MCCs (n=10), and
caregivers of their patients aged ≥65 with MCCs (n=10) to understand key perspectives on experiences
with assessing, managing, and communicating about treatment burden in primary care for older adults with
MCCs. These aims will be undertaken in conjunction with career development activities focused on 1)
prediction modeling using large observational data, 2) qualitative methods, and 3) research for older adults
with MCCs. This proposal will advance our understanding of strategies to estimate treatment burden and
to incorporate this information into primary care decision-making for older adults with MCCs, and inform
future work developing strategies to reduce treatment burden for older adults with MCCs. It will also
provide critical research skills and data to support progress towards my long-term goal of becoming an
independent investigator reducing treatment burden and improving quality of life for older adults with
MCCs.

Public health relevance
PROJECT NARRATIVE Older adults with multiple chronic conditions (MCCs) are prone to experiencing high treatment burden due to the complexity of their care, yet no systematic approach exists to use data routinely collected in clinical care (e.g. accessible in electronic health record or claims data) to estimate their treatment burden and integrate this information in clinical decision-making. The objectives of this K38 StARRTS proposal are to develop a scalable model to estimate treatment burden among older adults with MCCs using routinely- collected Medicare claims data, and to understand patient, caregiver, and PCP perspectives on integrating treatment burden information in decision-making in primary care. Ultimately, this proposal will lead to the development of interventions to reduce treatment burden and improve quality of life among older adults with MCCs.